Neurobehavior, Neuropathology, and Risk Factors in Alzheimer's Disease

We are applying to renew the University of Washington Alzheimer's Disease Training Program (ADTP),
“Neurobehavior, Neuropathology, and Risk Factors in Alzheimer's Disease.” Our program focuses on
translational research in Alzheimer's disease (AD) and related dementias. The objective of our research training
program is to provide interdisciplinary training for basic science, clinical, and translational researchers so that
they will be able to advance both clinical and mechanistic hypotheses about the etiology, pathophysiology, and
treatment of AD and related disorders. Our training program remains the only formal program at the University
of Washington (UW) focused on training investigators to carry out basic mechanistic, clinical, and translational
research in AD and related neurodegenerative dementing disorders.
Our program is supported by the rich and interactive research environment of the UW and Veterans Affairs
Puget Sound Health Care System, where a critical mass of faculty conduct research across the spectrum of AD
and related dementias. The program requests funding to maintain the currently funded positions for 7
postdoctoral trainees and 4 predoctoral students. Postdoctoral PhD candidates come from a broad range of
disciplines, including clinical psychology, neuropsychology, biochemistry, genetics, neurobiology, and
pharmacology. Basic science trainees typically join the program during their first year of postgraduate training
and remain for three years. Incoming MD postdoctoral candidates are expected to have completed a residency,
usually in psychiatry, neurology, neuropathology, radiology, nuclear medicine, internal medicine, or geriatric
medicine. MD and clinician PhD fellows are expected to remain for a two-year period and will be strongly
encouraged to remain for a third year. Predoctoral trainees will be recruited from the following UW PhD programs:
The Medical Scientist Training Program, Genome Sciences, Molecular Basis of Disease, Molecular and Cellular
Biology, Neuroscience, and Pharmacology programs; recruited predoctoral trainees will join the ADTP program
in their second or third year of graduate training. Direct recruitment efforts are made to include underserved
minority trainees.

Public health relevance
Alzheimer's disease (AD) and related dementias affect a growing number of people as the population ages. Currently, nearly 6 million persons in the US have AD; it is estimated that by the year 2050, that number will be 14 million. With this increase in the number of AD patients, there is a corresponding growth in the number of family members and other caregivers affected by this devastating disease, as well as dramatic social and economic costs. The goal of our research training program is to prepare a new generation of investigators to translate mechanistic scientific discoveries into effective tools for diagnosis, treatment, and prevention of AD and related dementias.